Managing Alpha-1-Antitrypsin Deficiency (AATD) through Proteostasis Signaling Pathways

Project Summary/Abstract:
Alpha-1-antitrypsin (AAT) deficiency (AATD) is the most common, underdiagnosed inherited genetic condition
(1:1500) and the primary modifier for chronic obstructive pulmonary disease (COPD) (300 million patients world-
wide- 3 million deaths annually). AATD is an aging and genotype sensitive disease. Onset and progression
results from misfolding of variant (mutant) forms of AAT in the endoplasmic reticulum (ER) of the liver leading to
aggregation triggering progressive liver disease, and subsequent loss-of-function of neutrophil elastase (NE)
inhibitory activity in serum and the lung leading to pulmonary failure by mid-to-late decades of life. Effective
treatment of AATD is a critical unmet need. This proposal addresses an emergent challenge to understand how
diverse variants in the AAT protein encoded by the genome of the world-wide population differentially contribute
to both gain- and loss-of-function disease pathology and how proteostasis (the protein folding program in the
cell) involving the unfolded protein response (UPR) ATF6 and IRE1/XBP1s signaling pathways, can be
manipulated by small molecules to therapeutically manage disease in the individual harboring a unique variant.
ATF6 and IRE/XBP1s signaling pathways adjust the capacity of the ER associated protein folding machinery
including the cytosolic heat shock protein (Hsp) 70 (Hsp70) ER paralog Grp78/BIP/HSBA5 chaperone/co-
chaperone system and the Hsp90 ER paralog Grp94 to restore balance in response to misfolding and ER stress.
We now apply Gaussian process (GP) regression machine learning based variation spatial profiling (VSP), an
innovative yet well validated tool (described in 11 publications to date for multiple proteins) that we have
pioneered to advance our understanding of the spatial covariance (SCV) relationships dictating AAT fold design
to develop novel therapeutic approaches for AATD. In Aims 1 and 2 we hypothesize that ATF6 and IRE1/XBP1s
signaling pathways, respectively, can be adjusted to mitigate AATD using small molecule activators of these
signaling pathways for nearly the entire spectrum of AAT variants in the patient population, experiments to be
performed in collaboration with our Co-Investigators Drs. Kelly and Wiseman at Scripps Research. We have
substantial preliminary data attesting to the effectiveness of UPR modulators across a broad spectrum of AAT
variants found in the patient population (Sun et. al., (2023) Cell Chem. Biol.). We propose that these efforts will
lead to effective, long term management AAT misfolding to mitigate severity of disease progression of AATD in
the clinic. In Aim 3, we hypothesize that a deep understanding of the role of UPR regulated components found
in the ER can explain the biology behind ATF6 and IRE1/XBP1s signaling pathway chemical modulators,
providing a solid mechanistic understanding of disease to direct drug development. Through a deep
understanding of GP based SCV properties of the collective of variants affecting AAT fold design driving
dysfunction in the world-wide patient population, we hope to discover how precise adjustments to the
proteostasis program can be used generate a precision perspective for therapeutic management of individual.

Public health relevance
Narrative: Alpha-1-antitrypsin (AAT) deficiency (AATD) related chronic obstructive pulmonary disease (COPD) is an aging sensitive inherited disease with onset and progression resulting from misfolding of variant (mutant) forms of AAT in the endoplasmic reticulum (ER) leading to gain-of-toxic aggregation in the liver and subsequent loss-of- function of neutrophil elastase (NE) inhibitory activity in serum and lung tissue- triggering progressive liver and lung failure by mid-to-late decades of life. This proposal addresses how specific branches of the protein folding machinery (proteostasis) involving the unfolded protein response (UPR) ATF6 and IRE1/XBP1s signaling pathways can be manipulated by chemical activators to protect the patient from disease in response to the diverse AAT variants encoded in the genome of the world-wide population by combined chemical, experimental and computational Gaussian process (GP) regression machine learning tools. We hypothesize that ATF6 and IRE1/XBP1s signaling pathways can be used to develop a new class of AAT folding correctors for nearly the entire spectrum of the AAT variant patient population, providing new mechanistic insights into the role of AAT in human liver and lung health and disease.